Home Monitoring of Metabolic Disorders

PROJECT SUMMARY
This proposal is submitted in direct response to NOT-HD-22-009 Notice of Special Interest (NOSI): Innovative
Technologies to Improve Assessments, Interventions, and Outcomes for Individuals with Intellectual and
Developmental Disabilities [IDD] (R43/R44). Persons of all ages with certain metabolic disorders are at-risk for
metabolic crises when a certain metabolite accumulates, while this metabolite can be measured in a clinical
laboratory, currently there is no home-based device to monitor the metabolie that causes the metabolic crises.
Our team’s long-term goal is to reduce the morbidity and mortality of metabolic crises associated with
certain metabolic accumulation. Through previous and ongoing National Science Foundation and National
Institutes of Health Small Business Innovation Research funding, we have developed an at-home device to
accurately measure this metabolite from a drop of blood and are working towards FDA clearance. The overall
objective of this proposal is to investigate the impact of daily home-based monitoring of the target metabolite
using the device we developed. This will be the first time that at-home measurement of the metabolite will be
measured in the target population at home.
Our central hypothesis is that when participants measure at-home, fasting, morning metabolite levels
there will be an association between getting an elevated metabolite result and then the patient taking further
action to contacting their medical team to further monitor or take steps to reduce the metabolite level.
Our specific aims are 1) to perform a clinical trial in 10 participants with disorders resulting in risk of
elevated metabolite levels, 2) to analyze the extensive data collected, and 3) to prepare a manuscript of the
results. To complete our approach we will recruit patients from the available patient population at Oregon
Health & Science University. We will collect extensive data from the participant medical record, observations,
and the device daily metabolite measurements.
This research is innovative because, for the first time, it provides a straightforward, home-based device
for measurement of the target metabolite. At the conclusion of this project, we expect to understand more the
impact of home-based metabolite monitoring on patient care.

Public health relevance
PROJECT NARRATIVE The objective of this R44 research is to test a new device to measure metabolite levels at home in patients at risk for metabolic crises. In the long term, home use of this device will enable physicians to better control patients to avoid metabolic crises and dramatically reduce the negative consequences of metabolic crises. Daily home monitoring of metabolic status will improve the lifelong outcomes of these vulnerable patients by enabling timely use of known and effective treatments for reducing metabolite levels to prevent or treat metabolic crises.